Impact of Diabetes hyperglycemia on peri-implantitis

Abstract.
During 10 years after dental implant placement approximately 30% of patients develop peri-implantitis, a disease
characterized by soft tissue infection and inflammation and bone resorption around implant. The associated
socio-economic burdens are significant, and patients often suffer from the chronic and distressing symptoms.
Recent studies suggested that Diabetes mellitus (DM) hyperglycemia is a risk factor of peri-implantitis. However,
it is unclear how hyperglycemia contributes to the pathogenesis of peri-implantitis. Without a clear understanding
of the mechanism and appropriate intervention, a large number of DM patients who receive dental implant
placement will continue to face the potentially higher risk of developing peri-implantitis. Our preliminary data
using a murine model of experimental peri-implantitis demonstrated that differential oral microbial compositions
were observed between hyperglycemic vs. normoglycemic mice, and hyperglycemic mice showed upregulation
of pro-inflammatory cytokines (IL-17 and IFN) and greater peri-implant bone loss compared to normoglycemic
mice after ligature-induced peri-implantitis. Based on the literature and our preliminary findings, the central
hypothesis for this project is that 1) DM hyperglycemia induces peri-implant dysbiosis through aggravated
systemic inflammation, and that 2) DM hyperglycemia-driven microbial changes promote peri-implant
inflammation and bone loss. In this proposal, we will investigate the causality of oral microbial change under
hyperglycemic condition and the effect of such change on peri-implant inflammation and bone loss in mice. In
Aim 1, peri-implant and periodontal microbial changes under normal vs. DM conditions with or without
intervention for inflammation and hyperglycemia will be identified and characterized by 16S rRNA sequencing
and metagenomic analysis. Microbiota profiles in lesions of peri-implantitis and periodontitis in the same animal
will be compared. Respective status of gingival inflammation and bone loss in the same animal will be determined
and analyzed under each condition. In Aim 2, we will first use an in vitro culture system to examine the responses
by oral mucosal epithelial cells and autogenous splenocytes to peri-implant microbiota from WT or diabetic mice
with or without intervention for inflammation and hyperglycemia. Then, peri-implant microbiota from WT or
diabetic mice will be transferred to WT recipient mice pre-treated with antibiotics, followed by the assessment of
peri-implant inflammation and bone loss in vivo. For further mechanistic analysis, we will test the role of IL-17
and IFN in hyperglycemia-associated peri-implant pathogenesis and characterize immune cell profile in peri-
implant soft tissue microenvironment using single cell RNA sequencing (sc-RNAseq). Successful completion of
this project will allow us to develop more comprehensive designs and translational approaches in the future to
gain insight into peri-implantitis pathogenesis in DM patients.

Public health relevance
Project Narrative The purpose of the current study is to determine the mechanism of diabetes mellitus (DM) hyperglycemia- associated peri-implant inflammation and bone loss. This application is relevant to public health because it will provide us with new knowledge about the pathogenesis of peri-implantitis in DM patients. The proposed research is relevant to the NIH’s mission because it will contribute to the future development of therapeutic strategies to prevent and treat adverse outcomes in people with peri-implantitis.